Rational Approaches to Melanoma Therapy

Project Summary – Overall
The overarching goal of this Patient Derived Xenograft (PDX) Development and Trial Center (T-PDTC) is to
develop functional precision combination therapies that can be translated into clinical trials to overcome drug
resistance and produce to long-term responses improving the outcomes of melanoma patients. The melanoma
treatment landscape has radically improved in the past decade due to availability of new immune- and targeted-
therapies available. Targeted therapies using BRAF and MEK inhibitors have been approved for patients with
BRAFV600E/K mutations, which are present in ~50% of cutaneous melanomas. These treatments elicit clinical
responses in ~80% of BRAFV600 mutant patients. However, most patients eventually progress. Additionally, there
are no effective targeted therapies for patients whose tumors harbor wild-type BRAF. Thus, there is an urgent
unmet clinical need to develop efficacious treatments to prevent or overcome resistance to current FDA-
approved therapies. To facilitate the development of new therapeutic strategies that can be translated into clinical
trials, we have developed a broad collection of PDX models that reflects the clinical, histological, and genetic
heterogeneity of melanoma. Our collection of >500 PDX models represents one of the largest collections for any
human malignancy. Our initial studies have demonstrated that our PDX collection recapitulates the molecular
heterogeneity observed in patients. This collection also includes a subset of PDX established from patients with
intrinsic and acquired resistance to targeted- and immune-therapies and rare melanoma subtypes. These efforts
have generated a robust pre-clinical resource to develop, refine, and prioritize new functional precision
combinatorial therapies for melanoma patients. This T-PDTC constitutes a multi-disciplinary and multi-
institutional Program focused on the use and continued expansion of our melanoma PDX collection and
organoids to identify new therapeutic combination approaches that will fill important clinical gaps. The Program
consists of two research projects and three Cores from a team that has worked extremely well together over the
last five years, publishing high-impact collaborative papers. The Research Projects are designed to develop
functional precision combination therapies for the most challenging types of melanomas: those that are resistant
to current therapies and tumors that lack BRAF-mutations (BRAFWT). We will map the molecular landscape of
our melanoma PDXs and organoids by integrating DNA, RNA, and protein data to nominate combination
therapies matching their molecular profile. We will develop and implement mechanism-based preclinical trials of
drug combinations in our large set of molecularly characterized PDXs. To do this, we will focus on NCI-
Investigational New Drug (IND) agents to advance melanoma precision therapy, while offsetting drug resistance
and producing durable responses. We expect to gain new mechanistic knowledge about the biology of drug
resistant melanoma that will lead to improved and durable precision therapies. We expect to identify biomarkers
to select tumors for specific treatments and provide data-driven recommendations for early phase clinical trials.

Public health relevance
Project Narrative – Overall Melanoma is a devastating disease, with increasing incidence worldwide. Although remarkable progress has been made treating melanoma, more than 60% of patients do not achieve long-term benefit. The central goal of this program is to develop functional personalized combination therapies to combat tumors that are resistant to current therapies. These studies are possible because we have a large bank of >500 melanoma patient derived xenografts which have been characterized based on DNA- and RNA-sequencing, and protein expression. We aim at matching novel combination therapies with the right patient based on the individual tumor profile; the knowledge obtained from these studies will be critical to prioritize clinical testing of novel combination therapies to improve patient’s outcomes.